Administrative, biospecimen and biostatistical core

SUMMARY CORE A: Administrative, Biostatistics, Clinical and Bionutrition Core
The Administrative, Biostatistics, Clinical and Bionutrition Core of this revised application will
provide scientific leadership, effective communication and budgetary and logistical support to
ensure the coordinated success of all Program Project activities. It will importantly also provide
specialized biostatistical and bionutritional expertise as well as perform the service of collecting
patient biospecimens and clinical data to support each of the three individual Projects. This
proposal seeks to build upon our established collaborative efforts and complementary expertise
of the Project and Core PIs, focusing on improving our understanding of how mucin-degrading
intestinal bacteria can aggravate HCT toxicities and developing novel therapeutics to target
mucin-degrading activity. Our goal in this funding period will be to lay the foundation and enable
clinical interventional studies that will evaluate novel strategies to reduce intestinal GVHD. Key
activities of this core include: administrative support for all of the investigators in each project
and core; fiscal management and oversight for each of the Projects and Cores; organization,
planning, and communication of Program Project meetings and activities, including internal and
external advisory board meetings. The overall goal of this Core is effective and efficient
leadership of the P01. The roles of the Director, Co-investigators and administrative staff are to
enable communication and provide an organizational structure while facilitating scientific,
technological and logistical interactions. In order to achieve this goal, the core has established
four objectives: (1) to coordinate interactions among key personnel in Projects and Cores,
internal and external advisory boards, and NHLBI personnel regarding effective implementation
of proposed objectives; (2) to provide biostatistical support for patient biospecimen analyses, as
well as in vitro and in vivo experiments and implement plans to enable data sharing; (3) to
oversee the clinical biospecimen and data collection from HCT patients at MD Anderson and
Duke; and (4) to provide bionutritional expertise for real time data collection from patients, data
analysis, and experimental approaches.